Expansion and Validation of Testing Methods for Food Contaminants in Animal Diagnostic Specimens

Project Abstract The Virginia Tech Animal Laboratory Services (ViTALS) is a Tier 1 Vet-LIRN laboratory housed within the Virginia-Maryland Regional College of Veterinary Medicine at Virginia Tech. As part of ViTALS, the Toxicology Laboratory has the experience, technical expertise, instrumentation and staff capabilities to validate methods to analyze biological samples. Minerals and vitamins are provided through the diet and their imbalance can be critical to animals. The toxicology laboratory currently analyzes diagnostic samples for metals, minerals and vitamin A and E. We propose to extend our capabilities to simultaneously quantify in the same extract vitamin A, vitamin E, vitamin D and its hydroxyl metabolites. We also plan to optimize and validate the analysis of a water-soluble vitamin, vitamin B1. Additionally, we will be collaborating with other Vet-LIRN labs for the validation of these methods in order to ensure robust methods that will be standardized for multiple locations to use in the event of an outbreak.

Public health relevance
Project Narrative Virginia Tech Animal Laboratory Services (ViTALS) at the Virginia-Maryland Regional College of Veterinary Medicine (VMRCVM) is a Tier 1 member of the FDA/Vet-LIRN laboratory network. Within ViTALS, the Toxicology Laboratory has the experience and expertise in analyzing biological and non-biological samples for contaminants. The ability to validate currently used analytical methods across multiple labs will ensure the efficient testing of samples of both feed and of diagnostic samples in the event of an outbreak.